Vision Training Grant

ABSTRACT
This is an application for continued funding for the Vision Training Grant (VTG) at the University
of Washington which includes 26 preceptors in seven Departments and six Interdepartmental
Programs. Our goal is to train the next generation of independent vision scientists to
communicate and access techniques broadly across vision sub-fields, and to appreciate the
links between fundamental and clinical research with the aim of developing treatments for
diseases of the visual system. Funds are requested to provide training for four pre- and two
postdoctoral trainees in the effective communication of scientific principles to a broad audience,
in grant-writing as a pathway to independence, and to provide exposure to a broad range of
topics and techniques in vision research ranging from individual proteins and molecules to
systems-level neuroscience and cognition. Trainees will participate in monthly discussion
sessions where a wide variety of topics including rigor and reproducibility in research, effective
data presentation, grant-writing, ethics and alternative career options will be discussed.
Trainees will present their work twice each year, attend VTG seminars and participate in VTG
lunches with visiting speakers, prepare an independent grant for submission and participate in
training for responsible conduct, and rigor and reproducibility in research. Postdoctoral trainees
are also required to participate in “Hit the Ground Running”, a mentoring program for postdocs.
Trainees will also receive mentorship related to the successful completion of research projects
and options for alternative careers. Predoctoral trainees will be supported for two years and
postdoctoral trainees for one year. The VTG is currently the only source of support for pre- and
post-doctoral trainees who want to commit to biomedical research in Vision and Ophthalmology.
As metrics of trainee outcome, we note that over the past two 5-year epochs, 36 of 38 trainees
have remained in research careers and 16 have won independent grants following their VTG
period. This includes 14 from the NIH (NRSA/K99). In summary, the VTG community at UW has
a demonstrated record of success in training; we have 26 preceptors with secure funding and
strong mentoring skills pursuing a wide range of research problems in Vision. We have large
predoc and postdoc populations that can benefit from the additional, dedicated vision training
supported by the T32. For the upcoming cycle, we request an increase in the number of predoc
slots from 2 to 4, and a continuation of 2 postdoc slots.

Public health relevance
NARRATIVE PUBLIC HEALTH RELEVANCE: Basic and clinical research can be expected to have a dramatic and constructive impact on visual disabilities. The Vision Training Grant at the University of Washington supports research and education of young scientists who will make the next generation of advances to conquer biomedical problems in vision and ophthalmology. The opportunities for vision training at the University of Washington are multidisciplinary and cover a broad spectrum of disciplines from cellular and molecular biology to systems biology, visual perception and computational neuroscience and we welcome the opportunity to contribute new solutions to help decrease blindness and morbidity in the world.